Diffusing persuasive HIV testing messages: engaging Black sexual and gender minority youth social media influencers

PROJECT SUMMARY
The combined mentorship, training and research in this K01 award will support the candidate’s long term
goal of formulating high impact, community-engaged HIV health disparities and social media-based
research focused on sexual and gender minority youth (SGMY) of color in the South. HIV remains an
insidious public health concern among Black SGMY in the South. Diagnose is one of the 4 Pillars of the
Ending the HIV Epidemic (EHE) Initiative and routine testing is a clear priority for this population.
Infrequent or never testing for HIV has been associated with high rates of infection in Black SGMY. Routine
HIV testing could provide a central gateway for linkage to HIV prevention services for those at risk or early
access to care for those unaware of their status; however, stigma-related barriers to testing persist (e.g,
internalized homophobia, HIV-related stigma). Stigmatized Black SGMY may be more isolated and many
turn to social media. Leveraging social networks, such as through Popular Opinion Leaders (POLs), via
social media can increase social support and destigmatize and normalize routine HIV testing. Despite its
popularity, Instagram has not been utilized in HIV-focused interventions, including among Black SGMY.
Instagram influencers are authentic and credible social media users who are, in essence, POLs. This project
proposes to enhance the EHE-recommended POL intervention promoting routine HIV testing in Black
SGMY in New Orleans. The project will employ 8 Black SGMY Instagram influencers to implement a novel,
theoretically-grounded approach to crafting persuasive HIV testing messages to their followers. To this
end, the candidate will: 1) Explore HIV testing attitudes and experiences and the use of non-stigmatizing
Instagram messaging to increase routine HIV testing for Black SGMY in New Orleans; 2) Identify, recruit
and train Black SGMY Instagram influencers on HIV knowledge and social-media based messaging
strategies using a novel framework for persuasive messaging; 3) Co-develop and deliver persuasive routine
HIV testing Instagram messages with Black SGMY Instagram influencers. A team of experienced mentors
with expertise in Black SGMY health disparities, HIV intervention development, persuasion theory, social
media messaging and community-based participatory research (CBPR) will guide the candidate through
the research. The diverse training plan will consist of multidisciplinary didactic coursework, individualized
training workshops and mentoring sessions, which will allow the candidate to: 1) Understand how the
intersection of multiple stigmatized identities (i.e., racial, gender and sexual) and related experiences
contribute to HIV-related disparities among Black SGMY; 2) Develop proficiency in persuasive social
media-based health communication strategies; 3) Gain skills in the development/ adaptation,
implementation and evaluation of interventions utilizing CBPR. This K01 award will give the candidate the
additional skills and experience needed to achieve research independence.

Public health relevance
PROJECT NARRATIVE Infrequent or never testing for HIV has been associated with high rates of infection in Black sexual and gender minority youth (SGMY) indicating a public health imperative to increase routine HIV testing. Social media influencers have been successfully used in consumer marketing; however, they have not been leveraged for HIV prevention efforts despite their potential as a scalable and cost-effective approach for public health intervention. This project will identify and train Black SGMY Instagram influencers, for the first time, to develop and deliver theoretically-grounded persuasive Instagram messages to promote routine HIV testing to their social media networks.